Biostatistics and Bioinformatics Core

CORE B: ABSTRACT
The Biostatistics and Bioinformatics Core (Core B) is a central component of the Prostate SPORE, providing
state-of-the-art integrated data science support to all Prostate SPORE projects. Database development and
maintenance will provide a centralized resource for data tracking for preclinical studies, ensuring efficient
reporting and statistical analysis of all experiments. In addition, clinical databases will be enhanced and
developed in conjunction with all project teams to complement existing clinical trial data registries at
Northwestern and ensure custom data capture in a highly secure environment. Bioinformatics activities of Core
B are central to discovery and will help define new and significant research directions. The large omics data
sets that will be generated in the Prostate SPORE Projects require specialized expertise for preprocessing,
analysis and interpretation of molecular and biological consequences of genetic manipulations and treatments.
Bioinformatics functionality provided by Core B will provide this crucial assistance for all proposed Prostate
SPORE Projects. Biostatistical activities of Core B are central to the concerns of rigor and reproducibility: by
providing study design guidance, data management, statistical analysis and consultation for interpretation of
results the core will see that reported results have been rigorously controlled and will be reproducible by others.
All functions of the Core B will be conducted in association with the following Specific Aims: AIM 1: Maintain and
enhance the pre-clinical, clinical and tissue databases of the Prostate SPORE; AIM 2: Provide state-of-the-art
bioinformatics expertise to the Prostate SPORE projects; AIM 3: Provide experimental design guidance and
biostatistics collaboration and analysis support for all preclinical studies and clinical trials Through these activities
Core B will serve as a key contributor to all individual projects and will ensure that project output is accurate,
reliable, and of the highest quality.

Public health relevance
CORE B: NARRATIVE The Biostatistics and Bioinformatics Core (Core B) has three primary responsibilities: 1) development, maintenance and enhancement of preclinical and clinical database functionality to support all Prostate SPORE Projects; 2) application of state-of-the art bioinformatics pipelines for pre-processing and analysis of high- dimensional omics data; and 3) biostatistical contribution to study design, data analysis and interpretation of results for all preclinical and clinical Prostate SPORE Projects to ensure that all reported program accomplishments undergo rigorous evaluation.